PET SCAN IN SCHIZOPHRENIA

This study attempts to quantify changes in regional cerebral mu opiate receptors and glucose metabolites using 11C-carfentanil and 18F fluorodeoxyglucose (FDG) PET in familial disease and to relate these changes to cognitive and neuropsychological parameters of disease.